CISNET Lung Disparities Supplement

Project Summary Abstract Lung cancer is the third most common cancer in the U.S and the leading cause of cancer deaths. Although lung cancer incidence and mortality in the US are decreasing, important differences by gender and race remain. Despite having lower smoking rates than other racial groups, Black men face the highest incidence and mortality rate of lung cancer in the US. Similarly, Black women have lower smoking rates than White women in the US, but have comparable lung cancer incidence and mortality rates to White women and higher lung cancer rates than other racial/ethnic groups. Lung cancer incidence by histology also differs greatly by race/ethnicity, with Black men and women being at higher risk for squamous cell carcinoma than other racial/ethnic groups. Given the observed heterogeneity in screening efficacy by histological type, these differences could affect the effectiveness of lung cancer screening in the Black population. The CISNET models of lung cancer natural history have been useful tools to understand the impacts of preventive interventions (tobacco control and screening) on lung cancer at a population level. We propose to extend and use one of the CISNET Lung models, MichiganLung, to 1) model lung cancer incidence and mortality in the US Non-Hispanic Black population (NHB), 2) determine the contributions of various factors along the cancer control continuum to disparities in lung cancer mortality in NHB relative to the whole population, and 3) evaluate the potential impact of screening and other interventions to reduce lung cancer burden and existing disparities in NHB.

Public health relevance
Project Narrative Despite having lower smoking rates than other racial groups, Black men and women face high rates of lung cancer incidence and mortality than other racial/ethnic groups. The Cancer Intervention and Surveillance Modeling Network (CISNET) lung cancer models have been useful tools to understand the impacts of preventive interventions (tobacco control and screening) on lung cancer at a population level. We propose to extend and use one of the CISNET Lung models, MichiganLung, to 1) model lung cancer incidence and mortality in the US Non-Hispanic Black population (NHB), 2) determine the contributions of various factors along the cancer control continuum to disparities in lung cancer mortality in NHB relative to the whole population, and 3) evaluate the potential impact of screening and other interventions to reduce lung cancer burden and existing disparities in NHB.